Administrative Component of the Global Leukodystrophy Initiative Clinical Trials Unit (GLIA-CTN)

Summary/Abstract for the GLIA-CTN Administrative Core
The mission of the Global Leukodystrophy Initiative Clinical Trials Network (GLIA-CTN) is to advance the
diagnosis, management, and treatment of individuals affected by leukodystrophies, consistent with the broader
principles of the RDCRN. The GLIA-CTN Administrative Core provides administrative support to accomplish
these aims by uniting a global consortium across academic centers, patient advocacy groups, and industry
partners. Aim 1 will maintain and expand the activities of the GLIA-CTN Administrative Core. We will use
DMCC provided tools such as REDCap and Ambra Image repository as well as continued interactions with the
NIH, RDCRN, and DMCC. Expansion plans include a novel DMCC/CAVATICA-based leukodystrophy registry,
accessibility for a large legacy biosample set (>40,000 samples) via the NINDS-funded BioSEND repository, and
dashboarding of key disease metrics for accessibility. Aim 2 will refine procedural approaches for rigorous
FAIR data sharing. To ensure data is findable, we will work with the DMCC and deposit data in the NCATS
ITRB. We ensure that demographic data is sufficiently detailed to allow for harmonization via global identifiers,
and that it is accessible with proper authentication and authorization that protect patient privacy via the DMCC,
retaining data sets. Interoperability will be ensured by aligning and integrating all data, images, genomic
datasets, and samples contributed to various DMCC platforms. We use standard data language supported by
SOPs to ensure that data is reusable by industry, advocacy, and clinical partners. Together, these efforts will
create a secure and accessible data repository consistent with the broader goals of the RDCRN. Aim 3 will
enable a community of advocacy, clinical and industry stakeholders. We will continue to work with patient
advocacy groups and industry partners in projects such as dashboarding, individualized patient registries, key
candidate drug trials and upcoming gene therapy trials. With RDCRN’s continued support and resources, the
GLIA-CTN will continue to build a robust and collaborative translational research environment that will benefit
the leukodystrophy community. The overall expected outcome of the Administrative Core is maintenance and
creation of resources to support and engage a diverse group of leukodystrophy stakeholders across the
common goals of improving the diagnosis, management and treatment of individuals living with
leukodystrophy. We expect our team-based approach to continue to advance our common goals with broad
stakeholder engagement